INSULIN, INSULIN RESISTANCE, AND BREAST CANCER

To determine if women with breast cancer, compared to control women, have increased insulin resistance and hyperinsulinemia and assess the correlation between hyperinsulinemia resistance and circulating sex steroids.